Regulation of the intestinal stem cell compartment after hematopoietic transplantation

Intestinal injury is a major complication of allogeneic hematopoietic transplantation, limiting its wider use. The
immune system plays a pivotal role in causing intestinal pathology in graft vs. host disease (GVHD) occurring
post-transplant, but the immune system can also provide critical contributions to epithelial regeneration and in-
testinal repair. We have found that immune-mediated interactions with the intestinal stem cell (ISC) compartment
are important contributors to both the damage and regeneration occurring in the intestines in acute GVHD, and
the previous funding period resulted in several impactful contributions to understanding immunologic effects on
the ISC compartment after bone marrow transplantation (BMT), including that 1) the crypt base ISC compartment
is the initial site of donor T cell infiltration within the intestines, where their overproduction of Interferon-g (IFNg)
can directly induce Bax/Bak-dependent ISC apoptosis at high concentrations; and 2) Interleukin-(IL-)22 can di-
rectly signal to ISCs, promoting their survival and regeneration after damage, and it can be administered thera-
peutically post-BMT to promote thymic and intestinal recovery. IL-22 administration can also counteract toxicity
from corticosteroids, which reduce ISC proliferation and epithelial regeneration. The experimental work from this
project resulted in a multicenter clinical trial treating newly diagnosed gastrointestinal acute GVHD with recom-
binant human IL-22. In this renewal, we propose to build upon this progress and conduct a mechanistic evalua-
tion of immune-mediated and niche-driven epithelial regeneration in the context of allogeneic BMT.
Our new preliminary data indicate profound transcriptomic changes in the ISC compartment in GVHD, identifying
a novel pathway of IFNg/STAT1-mediated regulation of ISC c-MYC expression and epithelial regeneration. We
believe this pathway induces ISC proliferation at low concentrations of IFNg, whereas high concentrations induce
apoptosis. Our new data also indicate that Paneth cell loss may not be driving intestinal pathophysiology in
GVHD, and other secretory epithelial cells may also produce growth factors for the niche. Utilizing our experience
in ex vivo organoid modeling and ISC immunology, 3-D confocal imaging, and cytokine biology developed in the
initial funding period, as well as newly developed approaches for epithelial transcriptomics, we propose to ex-
plore these preliminary findings further by 1) investigating the importance of epithelial Myc expression post-BMT
using a newly developed model of conditional Myc deletion, 2) dissecting IL-22 and IFNg’s distinct and overlap-
ping JAK/STAT responses regulating the ISC compartment, and 3) ablating Paneth cells and other secretory
lineage cells to determine their importance for ISC maintenance and epithelial regeneration after transplant. We
will then build upon these insights to develop novel approaches manipulating epithelial JAK/STAT signaling and
niche function to promote intestinal recovery. This renewal will thus pursue basic mechanisms of transplant
biology, mucosal immunology, and stem cell research and extend them to translational investigations with the
potential to improve clinical outcomes for transplant patients and others suffering from intestinal pathology.

Public health relevance
PROJECT NARRATIVE Gastrointestinal damage is an important complication of bone marrow transplantation and an important cause of morbidity within the general population. The immune system is often involved in these processes, but little is known about the immune system’s role in damaging or supporting the stem cells that maintain the intestines. The purpose of this project is to study immune-mediated damage to the intestinal stem cell compartment and immune-mediated regulation of its regeneration in order to gain fundamental biologic insights into the interactions between the immune system and tissue stem cells, as well as to leverage these insights into the development of new therapies that can promote recovery after intestinal injury.